Pediatric Solid Tumor Microenvironment Atlas

OVERALL SUMMARY/ABSTRACT
The majority of solid tumors in children have a unique origin compared to those in adults, stemming from their
rise from embryonic cells. Despite this distinction, there is still limited understanding of the differences in the
microenvironments of these pediatric tumors compared to adult cancers, and how these differences might
contribute to lineage plasticity and treatment resistance. To address this knowledge gap, we propose a
comprehensive investigation into the spatial biology of these tumors. Our goal is to shed light on the specific
cells and mechanisms within the tumor microenvironment that play a role in inducing therapy resistance in
pediatric solid tumors. This research will focus on prominent pediatric cancers such as rhabdomyosarcoma,
neuroblastoma, and Wilms tumors. The primary goal of this multi-disciplinary Program is to establish a
comprehensive Pediatric Solid Tumor Microenvironment (PSTME) Atlas that would lead to discovering basic
mechanisms of de novo and acquired resistance to modern therapies, and uncovering tumor microenvironment
(TME) targetable vulnerabilities driven by resistance. The motivation for creating the PSTME atlas is the urgent
need to improve survival of patients with high-risk subtypes of the proposed cancers, and to decrease treatment-
related morbidities. By delving into the intricacies of the tumor microenvironment and its impact on treatment
response, we aim to advance our understanding of pediatric solid tumors and pave the way for more effective
therapeutic strategies. The Project will be supported by collaboration among two institutions with distinct and
unique resources and technologies, and complementary expertise: A) Children’s Hospital Los Angeles (CHLA)
group will provide well annotated tumor specimens with clinical information in an ethnically diverse patient
population, and lead in generating spatial proteomics data using pediatric and TME specific antibody panels. B)
California Institute of Technology (Caltech) group will provide innovative spatial omics technologies including
spatial transcriptomics and copy number, and novel data science approaches for integrative analysis of the
generated data. The samples will be selected to represent solid tumor diversity based on established clinical risk
stratifications, and critical points of transition (post chemotherapy response, relapse) to ensure capture of the
diversity of PSTME. The PSTME atlas will impact the community through generation of easily accessible TME
atlas providing a user friendly, searchable database of multiomics spatial analyses of common extracranial solid
tumors with clinical and outcome data. It will also provide novel computational pipelines for integration and
analysis of spatial data. These opensource tools will be made available to the community. In summary, the
significance of the proposed project is the establishment of an atlas that will allow discovery of fundamental
mechanisms of extrinsic cancer therapy resistance with the goal of leading to substantively improved probability
of cure coupled with reduced therapy-related morbidity for children afflicted with solid tumors.

Public health relevance
NARRATIVE Our proposal brings a unique resources and technologies to create a Pediatric Tumor Microenvironment Atlas by focusing on novel single cell spatial biology tools to identify extrinsic effects attributable to tumor microenvironment on lineage plasticity and therapy resistance of childhood solid tumors including rhabdomyosarcoma, Wilms tumor, and neuroblastoma. Through spatial transcriptomic and proteomic technologies, the project will focus on classification of immune and non-immune cells comparing diagnostic samples among responders versus non-responders, and evaluating effect of therapy on TME and lineage plasticity that could aid in identifying resistant tumor phenotype. Identification of shared TME-induced pathways and networks across pediatric solid tumors could provide insights in devising novel immunotherapy approaches that would improve outcome and reduce reliance on chemotherapies and their long-term toxic sequala in children with solid tumor cancers.